PFAS, Renal Hemodynamics, and Kidney Disease

Per- and polyfluoroalkyl substances (PFAS) are a large group of highly stable chemicals used in
the production of water-, grease-, and stain-repellent properties. PFAS are recognized as
persistent organic pollutants, detected in food and drinking sources, and can bioaccumulate in
humans. Epidemiological data indicate that PFAS are associated with a variety of negative health
effects including chronic kidney disease (CKD) and hypertension. Moreover, the deleterious
effects of PFAS may be exacerbated in individuals already at risk for CKD and hypertension. Yet,
the direct effects of PFAS on kidney function and disease remain poorly understood, especially in
susceptible populations. The goals of this proposal are to investigate the direct effects of PFAS
on renal hemodynamics and mechanisms of renal injury in rat strains (Sprague-Dawley (SD) and
Dahl Salt-Sensitive (SS)) with large differences in susceptibility of developing CKD and
hypertension. Our overarching hypothesis is that PFAS cause proximal tubule injury, renal vasoconstriction, hypertension, and ultimately ischemia-induced acute kidney injury (AKI), which is a major cause of CKD. As a corollary to our central hypothesis, we propose that the deleterious effects of PFAS will be exacerbated in Dahl SS rats, which are susceptible to developing CKD and hypertension.
Aim 1 will test the hypothesis that PFAS cause renal vasoconstriction and AKI over time. The
direct effects of PFAS on arterial blood pressure, renal blood flow, and glomerular filtration rate
will be assessed in conscious, chronically instrumented rats. Serum and urine concentrations of
PFAS will be measured by mass spectrometry to assess renal handling of PFAS and body
burden levels. In addition to renal pathology, the off-target pathological effects of PFAS will be
assessed in liver, heart, and spleen tissue. Aim 2 will test the hypothesis that pathogenic
signaling and renal pathology will evolve over time during the transition from initial proximal tubule
injury to the subsequent development of AKI. We will use an unbiased mass
spectrometry/proteomics approach to identify PFAS-induced pathogenic signaling pathways
associated with the initiation of proximal tubule injury, independent of changes in renal
hemodynamics, and the subsequent development of ischemia-induced AKI. Renal
hemodynamics, proximal tubule injury, renal pathology, and proteomics-based signaling
pathways will be assessed at the same time points to assess relationships between
pathophysiology, pathology, and molecular mechanisms. Preliminary data show that our
experimental model is well-suited to address these questions and that the experiments are
feasible. Our approach involves an investigative team with expertise in renal hemodynamics
(Dr.'s Polichnowski and Griffin), AKI (Dr.'s Polichnowski and O'Connor), PFAS and proteomics
(Ms. Grindstaff and Dr. Lau), and renal pathology (Dr. Youngberg), which will provide novel
insights regarding the pathophysiologic and molecular mechanisms mediating PFAS-induced
kidney disease and bioaccumulation.

Public health relevance
Per- and polyfluoroalkyl substances (PFAS), which are synthetic chemicals used to make a variety of consumer products, are detected in food and drinking sources, can bioaccumulate in humans, and are linked to numerous diseases, including chronic kidney disease (CKD) and hypertension. This proposal will investigate the molecular and physiological mechanisms by which PFAS cause kidney dysfunction and injury in rat models with large differences in susceptibility to developing CKD and hypertension. Results of this work will improve our understanding of how PFAS bioaccumulate and cause CKD and hypertension, which can be used to better inform the potential risks of PFAS on kidney function and disease in clinical populations.